NEUROHORMONES IN THE PATHOPHYSIOLOGY AND PATHOGENESIS OF DEPRESSION

The principal aims of this project are to 1) identify state-independent alterations in corticotropin releasing hormone (CRH)-mediated physiological processes that can be utilized in the identification of biologically vulnerable individuals as an essential step for future molecular genetic approaches to unipolar depression, and; 2) to determine abnormalities in the regulation and actions of CRH in depression that are relevant to the susceptibility and intrinsic pathogenesis of this disorder, as well as to abnormalities in growth, reproduction, metabolism, and immunity, and hence to long-term health. In our search for a state-independent marker, we employ three protocols that intensively study the HPA axis; a) assessment of HPA responses to a naturalistic stressor (exercise at 70% and 90% V02max [Ex90, Ex70]); b) deconvolution techniques to assess instantaneous ACTH and cortisol production rates; and c) analysis of pulsatile hormonal secretion utilizing non-linear dynamics and low dimensional stochastic chaos. Our assessment of HPA responses to Ex90 in patients with seasonal affective disorder revealed a state-independent hypothalamic CRH deficiency similar to what we have previously observed in other syndromes of atypical depression. We have identified a sub-group of controls that shows HPA hyper-responsivess and GH hyporesponsiveness to Ex90, and increased trait anxiety. In a study of 20 consecutively admitted patients with affective disorder, we found a clinically significant decrease in the density of trabecular bone in association with decreased plasma osteocalcin levels (a potent osteoblastic factor), as well as a significant increase in intra-abdominal fat mass. These defects often persisted for months or years after resolution of the depressive episode and are potentially attributable to CRH mediated alterations in pituitary-adrenal, growth hormone, and gonadal steroid secretion. We also found that core CRH responsive elements in the POMC promoter have high homology to key elements of the genome of viruses (human immunodeficiency virus and cytomegalovirus) as well as to oncogenes and genes involved in the encoding of immune mediators such as IL-1 converting enzyme; thus, CRH could potentially influence susceptibility to infectious, neoplastic, or inflammatory diseases. In experimental models of cerebral ischemia in the rat, we have also found that CRH acts as an endogenous neurodegenerative agent that enlarges the area of infarct, while the IL-1 receptor antagonist serves as an endogenous neuroprotective agent potentially protecting the organism from the consequences of ischemia or other profound stressors.